Lateral Hypothalamic Circuits for Feeding and Reinforcement

Abstract:
Motivated behaviors such as feeding and reward-seeking are critical for an organism's survival. These
processes require distributed neuronal networks and supporting cell types in multiple brain regions to be tightly
regulated and tuned in order to orchestrate behavioral output. The lateral hypothalamic area (LHA) has long
been identified as a critical neuroanatomical substrate for motivated behavior. Despite decades of research,
the molecular identity of defined LHA cell types remains poorly understood. Additionally, while LHA neurons
have been previously shown to encode appetitive and consummatory behaviors via distinct cellular ensembles,
it remains unknown how distinct LHA output neurons contribute to these processes. Here we propose to
continue to study the neural circuits of the LHA, and to identify how distinct cell types contribute to feeding and
reinforcement. Using an interdisciplinary approach to leverage cutting edge tools such as single cell
transcriptional profiling, two photon calcium imaging, and viral we aim to undercover key circuit elements, and
novel circuit specific gene expression patterns that can be leveraged for future therapeutic interventions for
addiction and other neuropsychiatric disorders.

Public health relevance
Project narrative: Addiction and other mental disorders arise from disruptions in brain circuitry important for natural reward processing and motivation. However, the precise cell types and circuits that control adaptive reward seeking remain poorly understood. The proposed experiments will continue to investigate the neurocircuit architecture and function of genetically defined cell types in the rodent lateral hypothalamic area to better understand circuity implicated in these disorders.